Targeting Chromosomal Instability in the Evolution of Resistance to Matched Therapies Against Colorectal Cancer to Extend Treatment Response

PROJECT SUMMARY
Therapies targeting oncogenic drivers have revolutionized the treatment of metastatic colorectal cancer (CRC)
with new agents holding the potential to target most CRCs in the not-too-distant future. However, the impact of
these new therapies has been limited by the short duration of response in the clinic; most patients with CRC
progress within six months of starting targeted therapy. This proposal aims to address this problem of rapid
resistance. Our analysis of acquired resistance to BRAF and KRAS G12C selective inhibitors indicates that gene
amplification is a recurrent and often early mechanism of resistance in CRC. In our preliminary data, the
development of gene amplifications at progression and the detection of amplifications at baseline prior to
targeted therapy are both associated with shorter time on treatment. We hypothesize intrinsic tumor features
enable a program of enhanced chromosomal instability that underlie rapid resistance to targeted therapy in CRC
and that create a therapeutic vulnerability that can be exploited. Gene amplifications at resistance are often
carried as extra-chromosomal DNA (ecDNA), which can be dynamically regulated in response to changes in
drug levels. Beyond intrachromosomal amplifications, amplifications on ecDNA allow massive induction of
expression of the amplified genes, while maintaining high intratumoral heterogeneity, enabling cancers to
maximize their response to changing environments. These amplifications develop through chromothripsis, a
process in which multiple rearrangements occur during a one-off cellular crisis, and require intact double-
stranded DNA break repair pathways to form. In this proposal, we will evaluate how intrinsic tumor features
modulate development of targeted therapy resistance and test a novel combination approach to prevent the
development of resistance. Through deep analysis of clinical samples previously collected from patients with
CRC who received targeted therapies, cell lines, and patient-derived xenograft (PDX) models, we will evaluate
levels of markers of chromosomal instability, including amplifications, ecDNA, micronuclei, and fraction of
genome altered. Cell lines will be used to map out the timing of increased chromosomal instability leading to
resistance, and PDXs will be used to interrogate the effects of baseline tumor features on the time and nature of
resistance that emerges in CRC. Using PDX models of BRAF V600E and KRAS G12C CRC, we will test a novel
therapeutic strategy of combined DNA repair inhibition and targeted therapy to prevent resistance. We will
specifically test DNA repair inhibitors against ATM, ATR, DNA-PK, and ecDNA given with matched targeted
therapy from the start of treatment to prevent resistance. We believe this novel approach has the potential to
transform targeted therapy for CRC and improve outcomes for patients.

Public health relevance
PROJECT NARRATIVE This proposal addresses the problem of rapid resistance to targeted therapies in patients with colorectal cancer. It is based on the idea that chromosomal instability underlies rapid resistance, is enabled by intrinsic tumor features, and creates a therapeutic vulnerability that can be clinically exploited. We plan to identify patients at high risk for rapid disease progression and develop new treatment combinations that prevent resistance, ultimately improving the outcomes of patients with colorectal cancer.